Longitudinal evaluation of optical and neural factors leading to juvenile myopia

Project Summary
The Project Summary remains unchanged from the original submission.
Projections indicate that over 50% of the world’s population will have myopia by the year 2050. To develop
successful myopia prevention programs, it is critical to first discern the optical image formation and visual
processing characteristics in children who develop myopia. Considerable evidence points to the quality of the
visual image and absence of blur as the main drivers for normal ocular growth and emmetropization. Human
eyes have complex optical, retinal and visual processing structures and functions. Any and all of these factors
affect the perception of image quality, and may, therefore, be catalysts of the failure to control ocular
elongation and myopia development in children. To better understand the mechanism(s) for the development
of myopia, these factors ought to be measured in the same children over a longitudinal period, prior to and
after the onset of myopia. The immediate objective of this prospective longitudinal study is to tease out retinal
image quality and visual processing factors that may contribute to the development of myopia. We will recruit
two groups of young children, limiting eligibility to only children who are either at high risk or low risk to develop
myopia during the duration of the study. The following factors will be assessed in each child at 6-month
intervals over a period of 3 years: (1) Optical quality of the image formed at the retina. We predict that:
dynamic accommodation is less stable prior to myopia development, causing degraded retinal images; and
children who develop myopia will show degraded image quality across the retina. (2) Retinal responses to
image blur will be measured using pattern electroretinography while subjects observe images blurred with
various types and amounts of simulated optical blur. We predict that children with impaired retinal responses
will develop myopia. (3) Processing of blur will be measured using blur detection and discrimination thresholds
and contrast sensitivity functions across the visual field to the same types of image blur described in (2). We
predict that visual processing of blur will be impaired in children who develop myopia. We will create individual
models of interactions between the three measures: optical image quality, retinal function and visual
processing. We predict that deficits in retinal image quality, retinal function and visual processing or their
interactions lead to a cycle of abnormal representation of blur, which would in turn cause the development of
myopia. Understanding the signals that activate myopia development will have a significant impact and will
help us and other researchers to design future clinical studies for the prevention and control of myopia.
Knowledge of the mechanism(s) for myopia development is essential for the design of effective individualized
interventions in children at risk for myopia, which can be assessed in subsequent clinical trials.
1

Public health relevance
Project Narrative The Project Narrative remains unchanged from the original submission. The proposed study is relevant to public health because here is an urgent need to prevent juvenile myopia (nearsightedness) — projections indicate that over 50% of the world’s population will have myopia by the year 2050. Furthermore, the increasingly earlier onset of myopia in children with consequent higher progression rates is generating an epidemic of potentially blinding, high myopia. As a necessary step in developing successful myopia prevention programs, this longitudinal project will help understand the ocular structure and visual function characteristics of myopia development in children with an investigation of ocular, retinal and visual processing factors prior to and after the development of myopia in children. 1